Longitudinal Study of Lipids and APOE in the Development of AD and AD Pathology

DESCRIPTION (provided by applicant): The E4 allele of the Apolipoprotein E (ApoE) gene is the strongest genetic risk factor for the onset of sporadic Alzheimer's disease (AD) identified to date. The roles by which ApoE influences amyloid-beta (A2) metabolism and non-A2-mediated mechanisms in AD pathogenesis, however, remain to be fully clarified. The literature, and our preliminary data, suggest that early alterations in peripheral lipids (sphingolipids, fatty acids, cholesterol and cholesterol esters) reflect brain functioning and pathology, and may interact with ApoE genotype in the development of AD pathogenesis, warranting human studies. Clinical and epidemiological studies of short duration, while important, will not contribute to our understanding of the earliest phases of AD pathogenesis because Alzheimer's pathology (A2 plaques and neurofibrillary tangles) begins decades before the emergence of symptoms and substantial neurodegeneration. Identifying factors years before the onset of AD that may modify the effects of ApoE4 in initiating and promoting AD pathology and the subsequent emergence of symptoms will uniquely contribute to the development of prevention strategies. Longitudinal studies of cognitively normal individuals with serial measures of Alzheimer's pathology in the living brain, as proposed here in the unique cohort of the Baltimore Longitudinal Study of Aging (BLSA), initiated in 1958, are necessary to understand the relationship between ApoE4 genotype, perturbations in peripheral lipids, their interaction, and later development of AD clinical symptoms and brain alterations. The BLSA is one of few human studies that could provide the unprecedented opportunity to systematically examine this relationship over a long follow-up. BLSA participants, cognitively normal at their first visit in the study (mean age: 63.4), have a mean follow-up of 14.3 years (SD = 6.5) and a maximum follow-up of 38.9 years. In the proposed study we will measure plasma lipid levels (sphingolipids, fatty acids, cholesterol and cholesterol esters) at three early visit in the BLSA study, roughly 5 years apart, for those aged 55 and over (n=1095), and at the last visit, as well as during the neuroimaging sub-study. The specific aims include examining the proposed peripheral lipids, changes in these lipids over a long follow-up, and their interaction with ApoE to predict: 1) decline in tests of memory; 2) incident MCI, all-cause dementia, and AD; 3) change in serial MRI measures of brain atrophy and white matter lesion burden over 10 years; and 4) amyloid-beta deposition on 11C-PIB PET scans. The lipids will be assayed using an already-developed targeted and quantitative lipidomic approach.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many potent risk factors for Alzheimer's disease (AD), including hypertension and high cholesterol, are most detrimental in mid-life, presumably at the emergence of AD pathology, but have less of an effect on AD risk in late-life. Identifying factors in mid-life that may modify the effects of APOE E4 in initiating AD pathology, and the subsequent emergence of symptoms, will uniquely contribute to the development of prevention strategies. The overall aim of the proposed study is to examine, in the 50-year Baltimore Longitudinal Study of Aging, whether plasma lipids measured in mid-life (sphingolipids, gangliosides, fatty acids, cholesterol and cholesterol esters) modify the association between APOE and cognitive decline, clinical onset of mild cognitive impairment or AD, and neuroimaging measures of brain atrophy and brain pathology. Project Narrative Many potent risk factors for Alzheimer's disease (AD), including hypertension and high cholesterol, are most detrimental in mid-life, presumably at the emergence of AD pathology, but have less of an effect on AD risk in late-life. Identifying factors in mid-life that may modify the effects of APOE E4 in initiating AD pathology, and the subsequent emergence of symptoms, will uniquely contribute to the development of prevention strategies. The overall aim of the proposed study is to examine, in the 50-year Baltimore Longitudinal Study of Aging, whether plasma lipids measured in mid-life (sphingolipids, gangliosides, fatty acids, cholesterol and cholesterol esters) modify the association between APOE and cognitive decline, clinical onset of mild cognitive impairment or AD, and neuroimaging measures of brain atrophy and brain pathology. __SpecificAimsTextDelimiter__ A. Specific Aims The E4 allele of the Apolipoprotein E (ApoE) gene is the strongest genetic risk factor for the onset of sporadic Alzheimer's disease (AD) identified to date. The roles by which ApoE influences amyloid-beta (Aβ) metabolism and non-Aβ-mediated mechanisms in AD pathogenesis, however, remain to be fully clarified. While presence of the ApoE4 allele does not dictate an AD diagnosis, it does increase risk and individuals with the E4 genotype tend to show earlier (or more severe) memory decline, onset of AD, hippocampal atrophy, and Aβ deposition on 11C-PIB PET. The literature, and our preliminary data, suggest that early alterations in peripheral lipids (sphingolipids, fatty acids, cholesterol and cholesterol esters [sterols]) reflect brain functioning and pathology and increase risk of AD. The overall aim of the proposed study is to examine, in the unique cohort of the Baltimore Longitudinal Study Aging (BLSA) followed since 1958, whether these lipids modify the association between ApoE and clinical onset of mild cognitive impairment (MCI) or AD, and neuroimaging measures of brain atrophy and brain pathology, including Aβ deposition and white matter lesion burden. The majority of clinical studies that have examined risk factors for developing AD and subsequent neurodegeneration have been conducted in patients with MCI or AD. Such studies, while important, will not contribute to our understanding of the earliest phases of AD pathogenesis because Alzheimer's pathology (Aβ plaques and neurofibrillary tangles) begins decades before the emergence of symptoms and before there is significant neurodegeneration. Moreover, many potent risk factors for AD, including hypertension and high cholesterol, are most detrimental in mid-life, presumably at the emergence of AD pathology, but have less of an effect on AD risk in late-life. Identifying factors years before the onset of AD that may modify the effects of ApoE4 in initiating AD pathology and the subsequent emergence of symptoms will uniquely contribute to the development of prevention strategies. Longitudinal studies of cognitively normal individuals with serial measures of Alzheimers pathology in the living brain, as proposed here with the BLSA cohort, initiated in 1958, are necessary to understand the relationship between ApoE4 genotype, perturbations in peripheral lipids, their interaction, and later development of AD symptoms and brain alterations. In line with the recent NIA program announcement, PA-09-217 entitled "The Role of Apolipoprotein E, Lipoprotein Receptors and CNS Lipid Homeostasis in Brain Aging and Alzheimer's Disease", we propose to use a targeted quantitative lipidomic approach for sphingolipids (e.g. ceramides, gangliosides), fatty acids (e.g. omega-3, omega-6), cholesterol and cholesterol esters to examine whether early measures of plasma lipids modify the effect of ApoE on the development and timing of AD and neuroimaging measures of brain atrophy and pathology in the BLSA cohort. The BLSA is one of few human studies that could provide the unprecedented opportunity to systematically examine this relationship over a long follow-up. BLSA participants, cognitively normal at their first visit (mean age: 63.4) in the study, have a mean follow-up of 14.3 years (SD = 6.5) and a maximum follow-up of 38.9 years. Ascertainment of dementia diagnoses began in 1985. A subset of 158 cognitively normal individuals received annual MRIs for up to 10 years, starting in 1994, and over 70 have been imaged at least once with 11C-PIB PET since 2005. In this study we will examine levels of the proposed plasma lipids at three early BLSA visits, separated by 5 years (and subsequent visits as defined by each aim), change in lipid levels over time, and whether they modify the effects of ApoE4 on a) decline in tests of memory; b) incident MCI and AD; c) change in MRI measures of brain atrophy and white matter lesion burden over 10 years; and d) amyloid-beta deposition on 11C-PIB PET scans. Fasting blood has been collected in all visits since 1958 and stored in a -80oC freezer. As the BLSA is an ongoing study funded through the NIA (no follow-up through the proposed study needed) and all in-person visits needed for the proposed study including neuropsychiatric data and dementia diagnoses, blood collection, ApoE genotyping and neuroimaging measures have been completed, this application will be cost-effective with great scientific benefit. We propose to add lipid assays to this already-existing wealth of data. Aim 1: To examine levels of the peripheral lipids and their interaction with ApoE, as predictors of a) performance on tests of memory, and b) incident MCI and dementia (all-cause and AD) among 1095 participants in the BLSA cohort with more than 15,000 person-years of follow-up. The lipids will be assayed a total of 4 times in the BLSA cohort: three times after age 55 with ~5 years between, and either at the last BLSA visit for those who remained non-demented or at the visit in which dementia or MCI was diagnosed. H1: Alterations in the proposed plasma lipid levels (sphingolipids, fatty acids, sterols) at baseline, change over the 3 early timepoints, average of the three early timepoints, and change in lipids between the baseline and last visit will be predictive of a) decline in tests of memory and b) clinically-diagnosed incident MCI and AD. H2: Participants with the E4 allele and altered lipids will have an earlier onset of AD than either alone. Aim 2: Examine, in the neuroimaging substudy of the BLSA (n=158), with serial scans from 1994-2005, the relationship between the proposed lipids, ApoE4 genotype and brain MRI measures including hippocampal atrophy, imaging-based spatial patterns of abnormality for recognition of early AD (SPARE-AD), and white matter lesion burden. The lipids will be assayed a total of 6 times in this sample: the first 3 from early in the study, as described in Aim 1; and the other 3 from the BLSA visits most closely associated with the first, midpoint, and last MRI scan. H3: Alterations in the proposed lipid levels (sphingolipids, fatty acids, sterols) from three plasma measures early in the study, and the lipid measures concurrent with the start of imaging will be predictive of rate of hippocampal atrophy, SPARE-AD abnormality score, and increase in white matter burden over the 10-year follow-up. H4: Change in the proposed lipids between the first, midpoint and last blood draw during the neuroimaging study will correlate with concurrent change in hippocampal volume (atrophy) between the first and last MRI scans, as well as with increase in SPARE-AD and white matter burden over the 10- year follow-up. H5: Participants with both an E4 allele and altered lipids levels in the three measures at midlife will have earlier atrophy and abnormality scores than either alone. Aim 3: Among the 70 participants with at least one 11C-PIB PET scan, examine the relationship between the proposed lipids and amyloid-beta deposition. The lipids will be assayed a total of 4 times in this sample: the first 3 from early in the study, as described in Aim 1, and the fourth at the BLSA visit most closely associated with the 11C-PIB PET scan. H6: Alterations in the proposed lipid (sphingolipids, fatty acids, sterols) in the three measures at midlife will be predictive of amyloid-beta deposition. H7: Change in the proposed lipids from the three measures in mid-life to the lipid measures concurrent with 11C-PIB PET scan will be predictive of amyloid-beta deposition. H8: Participants with both an E4 allele and altered lipids will have more amyloid-beta deposition than either factor alone. Having accomplished the specific aims of the study, we will have obtained unique information regarding the utility of the proposed peripheral lipids, changes in these lipids over a long follow-up, and their interaction with ApoE, to predict: a) decline in tests of memory; b) incident MCI and AD; c) change in MRI measures of brain atrophy and white matter lesion burden over 10 years; and d) amyloid-beta deposition on 11C-PIB PET scans. BLSA visits are quite extensive, covering 2.5 days. Therefore, we will also be able to examine the effects of several mediators or confounders on the above relationships such as demographic factors, vascular factors, and lifestyle factors including BMI, physical activity, and diet. Lastly, as the assays of the proposed lipids have not been conducted before in an epidemiological sample of this size, we will have the unique opportunity to quantify and establish normal values of the proposed lipids in the blood. With the exceptional characterization of the BLSA participants and incomparable researchers across disciplines, beyond cognition and AD, the assaying of these peripheral lipids will support future opportunities to examine the lipids in relation to other diseases (e.g. diabetes, cardio- and cerebro-vascular disease).